HYDROXYUREA ON RED BLOOD CELLS OF PATIENTS WITH SICKLE CELL ANEMIA

The purpose of this study is to provide enlightment to the mechanism of benefit of Hydroxyurea in sickle cell disease. This study will be an extension of CRC Protocol 676.